SYSTEMIC PROSTAGLANDIN E1 ON UREA SYNTHESIS/WHOLE BODY NITRGN METAB IN CIRRHOSIS

The aim of this study is to evaluate the metabolic effects of prostaglandin E1 administration in patients with liver cirrhosis and paired healthy controls. The hypotheses being tested are: 1) Prostglandin E1 significantly influences hepatic and whole body amino nitrogen economy in patients with liver cirrhosis; 2) Prostaglandin E1 produces a decrease in urea synthesis, and 3) Prostaglandin E1 might act on the peripheral tissues, through a decreased amino acid efflux, or increased amino-acid uptake and non-oxidative metabolism. To date 4 subjects have been enrolled. No data analysis has been done.